Integrative Pathways to Health and Illness

ABSTRACT - Overall
This revised application is in response to the U19 funding opportunity for the Midlife in the United States
(MIDUS) study. The mission of MIDUS is to study health, broadly defined, as an integrated biopsychosocial
process that unfolds across the decades of adult life. The baseline study was begun in 1995 with over 7,000
adults, including twins, aged 25 to 74. This sample has been followed for 20 years, and along the way, MIDUS
was augmented with city-specific sample of African Americans, and more recently, a newly recruited national
sample, known as the MIDUS Refresher. Using a multi-project design, comprehensive survey, biomedical,
and neuroscience data have been collected on MIDUS respondents. In addition, current P01 funding of
MIDUS has facilitated the completion of a 3rd wave of survey data and 2nd wave of cognitive data. We seek
funds in this application to collect longitudinal data for the Daily Diary Project, the Biomarker Project, and the
Neuroscience Project. We also request funds to initiate a new Gene Expression Project focused on the
expression of genes central to the body's immune-inflammatory response as well as a Retention-Early
Warning Project, designed to reinstate a portion of drop-outs from prior waves of data collection. These five
projects are supported by an Administrative Core, a Bio Core, and a Statistics Core. Across all projects and
cores, detailed responses have been assembled in response to concerns raised in the prior review. In
addition, the Overall Plan documents the enormous momentum that has grown up around the MIDUS study via
updates on data usage and scientific productivity, including the high volume of new publications (88) generated
just since this application was first submitted ten months ago.
MIDUS fills a unique niche among NIA-supported longitudinal studies, given its wide age expanse and its
unusual depth in psychosocial, biomarker, and neuroscience assessments, which permit a focus on the
neurobiological mechanisms and pathways through which sociodemographic and psychosocial factors
influence unfolding profiles of health and illness. A unique strength is the thematic focus on psychosocial
strengths, which are being used to explicate profiles of resilience in many adults confronted with varieties of
adversity. MIDUS also includes a national twin sample, thus offering unique opportunities to advance
knowledge of the interplay of genetic and environmental factors in understanding healthy or unhealthy aging.
Importantly, MIDUS has captured the attention of the scientific community: it is the most frequently
downloaded study at the National Archive of Computerized Data on Aging (NACDA). Nearly 700 publications
have been generated, many breaking new ground in forging linkages among sociodemographic, psychosocial,
and neurobiological factors to account for differing pathways to later life morbidity and mortality.

Public health relevance
RELEVANCE The public health relevance of the proposed research is that MIDUS will continue to advance knowledge of how psychological and social experiences in early and middle adulthood matter for later life health and well- being. Psychosocial factors are increasingly recognized as protective resources as people deal with various types of adversity and life challenge and MIDUS is explaining how and why psychosocial strengths promote resilience by showing their linkages to biological risk factors and brain-based assessments. Importantly, many of these psychosocial factors are modifiable, making them potentially useful targets for prevention and promotion of positive health among U.S. adults.